Prognostic and predictive clinical and proteomic biomarker discovery in GBM

The objectives are to define biological behaviors, survival and response in glioma through clinical data features and proteome driven stratification in order to optimize radiation therapy management and patient outcomes. 1) Exploring differential biomarker expression post-radiation therapy in relationship to recurrence and survival and existing data on proteins associated with predictive and/or prognostic value; 2) Replicating and extending possible differential proteomic biomarker expression pre- vs post-radiation therapy across large scale data sets (TCGA, CGGA); 3) Explore existing and novel statistical methodology in as pertaining to proteomic signals and merging these with clinical data.